Administrative Supplement: Population-Based Study of Social Determinants of Health and Quality of Cancer Care in HIV-Associated Cancers

PROJECT SUMMARY/ABSTRACT
Advances in anti-retroviral therapy have transformed HIV into a chronic disease. As death from HIV has
decreased for people living with HIV (PLWH), mortality from other chronic diseases of aging, particularly non-
AIDS defining cancers (NADC), has significantly increased. Winship Cancer Institute’s P30 cancer center
support grant and its Community Outreach and Engagement component have identified PLWH as a “Special
Population”, experiencing significant cancer disparities in our catchment area of Georgia. Multiple retrospective
database analyses have reported worse cancer outcomes, including survival, between PLWH vs HIV-
populations, but underlying reasons to explain significant differences in cancer care and survival outcomes more
fully remain to be elucidated. We propose two Specific Aims for this exploratory supplement: 1) generate a
population-based cohort of age- and stage-matched HIV+ and HIV- NHL patients derived from the Georgia
cancer registry; and 2) contact this cohort using established registry protocols and evaluate feasibility and
acceptability of validated tools and methods to investigate social determinants of health and multi-level factors
(patient, clinical, facility, provider, system) that might impact diagnosis, treatment and outcomes for both HIV+
and HIV- cancer cases through a mixed methods study design. These Aims are in alignment with the NIH OAR
research priorities related to HIV-Associated Comorbidities, Coinfections, and Complications that contributes to
increasing understanding of the causes, frequency, and clinical outcomes of HIV-related malignancies, as well
as research to reduce Health Disparities … in treatment outcomes of PLWH. Completion of these Aims will lead
to an extramural grant application to expand preliminary data to other NADC.

Public health relevance
PROJECT NARRATIVE People living with HIV (PLWH) are living longer but are at higher risk for being diagnosed with and dying from other chronic diseases, such as cancer. In addition to changes to the immune system from HIV and its treatment, PLWH may experience worse outcomes from cancer due to social determinants of health (SDOH), such as education level. This population-based study will examine how SDOH may impact cancer outcomes for patients with HIV positive or HIV negative cancer called non-Hodgkin lymphoma.